Analysis of Calcium Signaling in C. Elegans

Analysis of calcium signaling in C. elegans
The goal of this project is to analyze mechanisms controlling signaling by
voltage-activated calcium (CaV) channels. In neurons and muscles, brief cytoplasmic
calcium transients efficiently and rapidly activate downstream effectors, often on
millisecond time scales. One general mechanism that promotes signal speed and
efficiency is tight spatial coupling between CaV channels and their effectors, which is
termed calcium nanodomain signaling. We propose three Aims to study nanodomain
signaling by CaV channels. First, we identify genes required to promote coupling of
CaV1 (L-type) channels to two effectors, calcium activated BK potassium channels and
ryanodine receptors (RYR), which are calcium release channels in the endoplasmic
reticulum. Second, we test models for how the threshold is set for activity induced gene
transcription, and if this threshold is shifted by mutations in specific calcium activated
signaling components or by endogenous neuropeptides. Third, we ask how CaV1 and 2
channels are localized at presynaptic terminals, which dictates neurotransmitter release
probability. These Aims address fundamental mechanisms controlling neuron and
muscle physiology.

Public health relevance
Title: Analysis of calcium signaling in C. elegans Narrative: This proposal describes a coherent set of genetic, molecular, and biophysical experiments to determine how voltage-activated calcium (CaV) channels are coupled to their downstream effectors in neurons and muscles. CaV activation of effectors controls action potential firing patterns, muscle contraction, activity regulated gene transcription, and neurotransmitter and neuropeptide secretion. Thus, these Aims address fundamental aspects of neuron and muscle biology.